CONTINUOUS INFUSION TAXOL IN COMBINATION WITH THORACIC RADIATION IN LUNG CANCER

Determine the toxicity of the combination of continuous infusion of Taxol and standard radiation therapy in the treatment of locally advanced unresectable non-small cell lung cancer. Our ongoing focus is to enroll patients.